Decoding the role of the glycoproteome in Alzheimer’s disease and related disorders.

ABSTRACT
New therapies are needed for dementia and loss of ambulation that are impaired by Alzheimer's Disease and
Related Dementia (AD/ADRD) pathologies. Mechanisms underlying pathologies are unclear and pathologies
alone do not fully explain cognitive and motor decline. Proteome-wide studies have identified some proteins that
contribute to AD/ADRD pathologies and others that more fully account for clinical decline. Yet, the specific CNS
functions of many brain proteins requires posttranslational modifications (PTM), the most common being the
addition of sugars (glycans). Identifying novel glycopeptiforms underlying AD/ADRD traits to catalyze
mechanistic and drug discovery studies are scarce due to difficulties conducting glycoproteome-wide studies.
Using our new method, this study will elucidate the role of the glycoproteome in AD/ADRD. It will identify
glycopeptiforms related to AD/ADRD pathologies and clinical traits, test if glycopeptiforms link an active
lifestyle with brain health and characterize the genetic architecture of the brain glycoproteome and AD.
Compelling data support this study. 1) We identified >11,000 unique glycopeptiforms in a glycoproteome-wide
study of dorsal lateral prefrontal cortex (DLPFC; N=366). 2) Six glycopeptiforms were related to AD/ADRD
pathologies; 3) Eleven glycopeptiforms were related to cognitive decline; 3 were linked with cognitive decline via
AD/ADRD pathologies and 8 were associated with cognitive decline but unrelated to AD/ADRD pathologies and
may provide resilience. 4) Glycopeptiforms remained related to cognitive decline when controlling for protein
abundance in the same model, suggesting a separate effect for the glycopeptiform. 5) GO analyses indicated
that glycopeptiforms related to cognitive decline involve metabolic pathways. 6) Applying our bioinformatic
analysis identified additional glycopeptiforms related to cognitive decline. 7) The resilience glycopeptiform
(pentraxin-2) linked frequent social activities with slower cognitive decline. 8) Numerous common variants impact
protein glycosylation; some glycoQTLs are recognized as AD risk variants.
This postmortem study will use novel resources already collected from 800 decedents including annual clinical
measures, indices of 10 AD/ADRD pathologies, proteome, glycoproteome and Whole Genome Sequencing data.
Aims 1-2 will use novel integrative analyses to increase the yield of glycopeptiforms that are related to AD/ADRD
pathologies and clinical traits identified in our discovery cohort (n=366). Aim 3a will replicate our findings in a 2nd
test cohort (n=434). Aim 3b will increase our power by combining data from our discovery and test cohort. To
move beyond simple correlations, Aim 4 will test if the benefits of an active lifestyle are mediated via resilience
glycopeptiforms identified in Aim 3b. Aim 5 will examine the genetic architecture of the brain glycoproteome.
This study will provide novel high-value targets that may be druggable or underlie resilience behaviors, inform
on mechanisms underlying AD/ADRD pathologies and clinical traits and characterize the genetic architecture of
brain glycoproteome and AD risk. This study can advance AD/ADRD research and its clinical care.

Public health relevance
PROJECT SUMMARY The prevention of cognitive and motor decline related to Alzheimer's disease and related dementias (AD/ADRD) in aging adults is a major public health priority and new therapies are needed. This proposal will identify glycopeptiforms in the brain that are related to AD/ADRD pathologies and clinical traits, test if they link an active lifestyle with brain health and inform on the genetic architecture of the brain glycoproteome and AD risk. The glycopeptiforms identified, are high-value targets for mechanistic and drug discovery studies to catalyze new therapies that can advance AD/ADRD research and decrease the burden of AD/ADRD in millions of aging Americans by reducing its pathologies and maintaining cognition and motor function.